Contribution of chaperone-mediated autophagy failure to metabolic dysfunction-associated steatotic liver disease progression

PROJECT SUMMARY
Autophagy, the process of lysosomal degradation of cellular components, is a conserved homeostatic
mechanism with crucial roles in the maintenance of protein homeostasis (proteostasis) and in the cellular
response to stress through rapid organelle and proteome remodeling. A selective type of autophagy found in
mammalian cells, chaperone-mediated autophagy (CMA), facilitates the timely and selective degradation of
key soluble, cytosolic proteins involved in processes like the regulation of hepatic metabolism, the cell cycle, cell
death, and the cellular stress response. Basal and inducible levels of CMA decline with age, resulting in
widespread dysregulation of key cellular processes and aggravation of age-related diseases.
Metabolic dysfunction-associated steatotic liver disease (MASLD) is the most common chronic liver disease
in western countries. It represents the beginning of a spectrum of disease that can lead to hepatocellular
carcinoma, the third leading cause of cancer death globally. Progressive forms of MASLD are now the leading
etiology of liver transplantation in hepatocellular carcinoma patients. There is only one FDA-approved drug
targeting this pathology, despite its high prevalence and impact.
Because of CMA’s established roles in the regulation of hepatic metabolism, we hypothesized that CMA failure
may result in proteostatic and metabolic alterations that favor the development of MASLD. This proposal
contains exciting data supporting this hypothesis. The studies described leverage several already-established,
well-characterized genetically modified mice with deficiencies in CMA and a fluorescent reporter of CMA activity,
as well as small molecule chemical activators of CMA suitable for in vivo use. We aim to further elucidate CMA’s
hepatoprotective role, as well as the consequences of CMA failure and their mechanisms (Aim 1), and the impact
of pharmacologic CMA upregulation (Aim 2) during MASLD development and progression. This proposal will
synergize (via a co-mentorship) the Arias Laboratory’s expertise in liver physiology and pathobiology and the
Cuervo Laboratory’s expertise in CMA to discover previously unknown molecular mechanisms of chronic
liver disease. It may further identify CMA as a novel therapeutic target to prevent liver disease progression.
This fellowship funding will enable me to advance toward my goal of becoming an independent physician scientist
investigator by strengthening my technical abilities; expanding my background on liver pathophysiology,
metabolism, and autophagy; and improving my ability to formulate and test scientific hypotheses in a robust and
reproducible manner, as well as my scientific communication and presentation skills. The group of exceptional
mentors and collaborators assembled for this application will aid in assuring timely completion of the proposed
project and a smooth transition into my clinical training.

Public health relevance
PROJECT NARRATIVE This project seeks to understand the protective role of chaperone-mediated autophagy (CMA), a process that cells use to selectively degrade proteins, against metabolic dysfunction-associated steatotic liver disease (MASLD). We will use genetically modified mice and selective small molecule drugs which have been designed by our laboratories to test if alterations in CMA activity could be one of the molecular mechanisms underlying MASLD, the most common chronic liver disease in America. This study will advance the foundational understanding of MASLD and may potentially identify new therapeutic strategies for patients affected by this disease, for which there is only one FDA-approved drug.